Leveraging Automated Optimization of Inspired Oxygen and Oxidized Biomarker Lipidomics for Targeted Oxygenation during Mechanical Ventilation: a Pragmatic Clinical Trial

PROJECT SUMMARY:
Candidate: The candidate, Sonal Pannu, M.D. is an early career investigator from the division of Pulmonary,
Critical Care, and Sleep Medicine at the Ohio State University and has an excellent academic track record. She
has demonstrated persistent interest in clinical and translational research for improving the safety of mechanical
ventilation, focusing on prevention of hyperoxia and hypoxemia. In addition, she has developed bioinformatics
related electronic algorithms for targeted oxygenation and is using oxidized lipidomics biomarkers to determine
optimal oxygenation targets. Her short-term goal is to augment the clinical researchtraining with advanced
training in pragmatic and novel clinical trial design, bioinformatics and associated statistics for development of
lipidomics biomarkers. Her long term goal is to become a successful independent clinical and translational
scientist leading a multidisciplinary research team focused on pragmatic clinical trials in the ICU for utilizing
lipidomics biomarkers for ascertainment of optimal oxygenation to improve outcomes of critically ill patients.
Career Development: Dr. Pannu’s career development will include plans enroll in formal training for conducting
pragmatic multi-center clinical trials; in lipidomics; in bioinformatics and associated statistics through didactics
and experiential learning. Environment: Dr. Pannu is currently in an environment that is extremely supportive
for her development as a clinical and translational researcher. There is a large ICU patient population
and support in the form of resources for clinical research, bioinformatics, clinical coordinators and laboratory
technicians. Dr. Pannu’smentors, Dr. Crouser (Ohio State University), Dr. Diaz (Ohio State University) and Dr.
Rice (Vanderbilt) have an outstanding history as mentors in addition her research advisory committee consists
of well-funded and accomplished researchers. Research: Dr. Pannu’s goal in this project is to study
an approach to targeted oxygenation goals through an automated oxygen titration strategy. Her specific aims
are: Aim 1: Determine the efficacy of an electronic health record based oxygen-titration strategy to
maintain arterial oxygen saturation validated, optimized targeted peripheral oxygen saturation range
and Aim 2: Analyze oxidized lipid biomarkers as markers of hyperoxia associated lung injury in
patients with the optimized targeted oxygenation strategy compared with usual care. To accomplish
this Dr. Pannu will conduct a pragmatic clinical trial with cluster randomization, stepped wedge
design to study targeted oxygenation with an automated protocol vs conventional approach by ventilator
management guidelines. She will assess short term (ventilator and ICU based) and long term clinical outcomes
(6 month follow up for cognitive function assessment). She will also measure and compare oxidized lipid
biomarkers within the two groups to determine the oxidized biomarker profile for optimal oxygenation and
correlate their expression to the degree ofoxygen exposure and ventilator-free days.

Public health relevance
Project Narrative Oxygen is a lifesaving therapy but needs to be balanced since both high and low extremes are harmful. This proposal describes an innovative approach to maintain targeted oxygenation preventing both extremes. The proposal also looks at identifying biomarkers of oxygen toxicity, which can help health care workers prevent oxygen induced toxicity and result in shorter time on mechanical ventilation, less organ failure and better life quality after illness.